Delirium, Acute Inflammation, and Rhythmic Transcriptomics (DART)

PROJECT SUMMARY
Postoperative delirium in older adults imposes massive burdens on patients, family members, and hospital
systems
with United States costs upwards of
$32 billion. Despite this, the pathophysiology of postoperative
delirium remains poorly understood and no therapies exist.
Disruption of the circadian clock system is a putative contributor to postoperative delirium. The circadian clock
system coordinates the timing of most physiologic processes including the systemic inflammatory response,
whose dysfunction has been linked to postoperative delirium incidence and severity. It is unknown whether acute,
perioperative disruption of the circadian clock system leads to an aberrant systemic inflammatory response to
precipitate postoperative delirium. Elucidation of these dynamic, bidirectional relationships may yield novel
predictive biomarkers and therapies to reduce delirium risk.
We have recently validated a machine-learning algorithm, TimeSignature (TS), that uses transcriptomic data
from whole blood to measure internal circadian transcriptomic time in a cohort of older adults. TS can be used
to determine the transcriptomic angle, or the magnitude of discrepancy between internal transcriptomic time
and true time of blood sampling in an individual. In this proposal, we aim to determine temporal links between
changes in transcriptomic angle, systemic inflammation, and delirium severity in a cohort of older adults
undergoing elective cardiac surgery. The central hypothesis is that patients stratified by delirium severity will
exhibit distinct longitudinal molecular patterns of circadian rhythms and systemic inflammation perioperatively.
In Aim 1, we will determine whether patients stratified by delirium severity exhibit distinct longitudinal patterns of
transcriptomic angle across the perioperative continuum. Older adults stratified by delirium severity will undergo
serial measurement of transcriptomic angle at three perioperative timepoints: on the day before cardiac surgery,
on postoperative day (POD) 1, and POD 4. In Aim 2, we will evaluate whether incorporating proteomic biomarker
data enhances distinguishing longitudinal patterns among delirium severity groups. The same patients from Aim
1 will undergo serial measurement of a comprehensive panel of protein biomarkers related to acute inflammation
and neurobiological injury. The contribution of this proposal is significant because it represents critical first step
in establishing the clinical relevance of molecular circadian rhythm disruptions during the perioperative period.
The proposed research is innovative because it will shift current delirium research paradigms towards a
precision-based approach ideally suited for hospitalized and critically-ill older adults undergoing major surgery.

Public health relevance
PROJECT NARRATIVE Postoperative delirium is an acute neurologic disorder that is common in older adults requiring major surgery and general anesthesia with United States costs upwards of $32 billion annually. Although altered inflammatory response to surgery has been theorized to contribute to postoperative delirium, no studies have determined whether acute disruption of the molecular circadian clock system, known to tightly regulate the acute inflammatory response, also plays a role. Investigating the temporal relationships between degrees of molecular circadian rhythm disruption, systemic inflammatory response, and postoperative delirium severity in older adults will lay the groundwork for future precision-based biomarkers and therapies for mitigating delirium risk.